Physical aspects of Drosophila Gastrulation

The proper function of organisms, their organs, and their tissues requires them to have specific
shape. How this shape is specified and maintained is a fundamental question in biology. In
animals, the shape is determined through the process of morphogenesis, a concerted sequence
of tissue remodeling events leading up to the final body plan. Despite a long-standing effort to
understand the physical mechanisms that underlie morphogenesis, these mechanisms still
remain largely unknown. Basic considerations from physics imply that in order to completely
determine the mechanism of a morphogenetic change, two pieces of information are absolutely
required: (1) material/mechanical properties of the tissue, and (2) the active forces that drive
tissue deformation. Using Drosophila gastrulation as a model, and by combining biophysical,
molecular, and modeling methods, we propose an approach sufficient to determine both.
Recent work from our group and others has begun the process of quantifying the mechanical
properties of tissues as whole. However, it has become clear that mechanical properties vary in
different cellular regions (apical vs basal etc.), and that understanding these differences is
crucial for correctly understanding and accurately predicting morphogenesis. In Aim 1, we
expand upon our previously established techniques for measuring tissue mechanics, and apply
them to directly measure viscous and elastic properties of the apical, lateral, and basal cellular
compartments separately. In Aim 2, we will incorporate these measurements into a
comprehensive computational model to explain large-scale tissue behaviors based on these
microscopic measurements. From this model, we will also be able to extract the spatial and
temporal force profiles driving tissue morphogenesis in the early embryo. In Aim 3 we will
assess the predictive power of our model to predict mutant phenotypes, and we will also begin
identifying the molecular players that contribute to specific mechanical features such as
elasticity and mechanical memory. In summary, successful completion of the project will for the
first time establish a comprehensive biophysical mechanism of a key model system. Both the
techniques and general approach developed here will be applicable to a wide variety of tissue
morphogenesis processes.

Public health relevance
Shape is critical for the proper functioning of most tissues and organs, and the ability to understand or manipulate the outcome of tissue morphogenesis has implications for both embryonic development and regenerative medicine. This project examines the mechanical properties of tissues and the forces driving morphogenesis, which is essential for understanding animal development.